An Efficacy Trial of Mobile Technology for Reducing and Preventing Adolescent Suicide

ABSTRACT
Suicide is a leading cause of death in the US and suicide rates have steadily increased. Despite this, there is a
paucity of interventions that reduce suicide ideation and behavior. In this project, we seek to enhance a beta
version of our suicide prevention digital therapeutic (developed in phase I) and conduct a randomized
controlled trial to evaluate the efficacy of the digital therapeutic for suicide-related outcomes. This
administrative supplement seeks to strengthen the proposed evaluation of treatment response and safety. This
project will contribute to our understanding of the use of mobile technology as a suicide prevention tool.

Public health relevance
PROJECTIVE NARRATIVE Suicide is the second leading cause of death among youth in the US; however, effective suicide prevention programs are often difficult to disseminate because their implementation is labor intensive. In response to this gap, Oui Therapeutics seeks to determine the efficacy of Aviva-Y: a mobile technology tool designed to help youth reduce their risk of suicide.